DEVELOPMENTAL FUNDS

Developmental Funds Funds are being requested to partially support outstanding junior investigators newly recruited to MSKCC. The research programs at the Center are continuing their planned expansion, particularly in areas considered to be of strategic importance. Some of these areas include: chemical biology, developmental biology, cancer biology, experimental pathology, immunology, and human genetics. MSKCC will be recruiting approximately fifty additional investigators over the next 5-8 years. A request is made to provide stable support for six investigators per year during their early start-up period.